Regulation of Telomere Maintenance in Fission Yeast

Project Summary/Abstract
Our laboratory is interested in understanding how eukaryotic cells ensure the maintenance of
telomeres, the natural ends of linear eukaryotic chromosomes. Evolutionarily conserved shelterin and
CST (CTC1/Cdc13-STN1-TEN1) complexes play essential roles in telomerase recruitment and
protection of telomeres against DNA repair and checkpoint factors. Stable maintenance of telomeres is
critical to preserve genomic integrity and prevent the accumulation of undesired mutations that might
lead to tumor formation. Regulation of telomere structures and telomerase also affect cell proliferation
and tissue maintenance in aging organisms. Therefore, basic mechanistic studies investigating how
telomere and DNA damage response proteins collaborate in proper telomere maintenance should
provide critical insights necessary to help devise more effective treatment strategies against tumors or
other age-related diseases. Our proposed research projects utilize the fission yeast
Schizosaccharomyces pombe. Fission yeast telomeres serve as a good model for human telomeres
since proteins involved in telomere maintenance are highly conserved between fission yeast and
humans.
Studies from our lab and others have provided detailed insights into how fission yeast shelterin and
Stn1-Ten1 ensure stable maintenance of telomeres in fission yeast. Those include findings that (1)
Tel1ATM/Rad3ATR-dependent phosphorylation of the shelterin subunit Ccq1 on Thr93 promotes
telomerase recruitment by promoting interaction between Ccq1 and the telomerase subunit Est1, and
(2) SUMOylation of another shelterin subunit Tpz1TPP1 on Lys242 facilitates Stn1-Ten1 recruitment to
telomeres and limits telomere extension. Evolutionarily conserved "TEL patch" residues within Tpz1
have also been found to promote telomerase activation and recruitment, further highlighting the well-
conserved nature of telomere regulation by fission yeast and mammalian shelterin. Our analyses of
temporal binding patterns for DNA polymerases, telomerase, shelterin, and Stn1 found that shelterin
subunits Rap1 and Poz1 and the Stn1-Ten1 complex promote timely dissociation of telomerase from
telomeres by promoting recruitment of Pola to complete lagging strand synthesis at telomeres. For the
current grant application, our proposed experiments will (1) identify and characterize the underlying
regulatory mechanism(s) that allow Ccq1 and Poz1 to promote Pola-dependent telomere protection
(Aim 1), (2) identify new interaction partners of Stn1-Ten1 complex and characterize their contributions
to recruitment/retention of Stn1-Ten1 complex at telomeres and non-telomeric sites (Aim 2), and (3)
investigate how regulation of TERRA vs. poly(A)+TERRA expression modulates Stn1-Ten1-Pola
recruitment at telomeres (Aim 3).

Public health relevance
Project Narrative Stable maintenance of telomeres is critical to preserve genomic integrity, and studies have found that defects in protein complexes that ensure telomere maintenance, could lead to various human diseases including cancer. The overall goal of this project is to provide detailed knowledge of the mechanisms that allow conserved shelterin and CST complexes to ensure stable maintenance of telomeres by controlling DNA replication at telomeres and attenuating DNA damage responses. Since proteins involved in telomere maintenance and DNA damage responses are very well conserved between fission yeast and humans, we expect our findings to help guide future studies of telomere regulation mechanisms in humans.